Targeting PCSK9 axis for castration-resistant prostate cancer recurrence suppression

SUMMARY
Metastatic castration-resistant prostate cancer (mCRPC) is the most recurrent and, fatal
phenotype. mCRPC patients have poor recurrence-free and limited preventive options. The
natural product pseurotin A (PS) dually suppressed PCSK9 secretion and interaction with LDLR.
PS suppressed 94% of PC-3 PC recurrence in nude mice model. PS antimigratory activity
significantly reduced when PCSK9 knocked-down. The small molecular size of PS is
advantageous over the FDA-approved humanized PCSK9 mAbs acting intra- and extra-cellular
unlike the later which can act extracellular only, reflecting better potency. Recently, PCSK9
proved critical driver for prostate and several other cancers. Project central hypothesis is
targeting extra- and intracellular PCSK9 axis with the small molecule PCSK9 inhibitor
pseurotin A can effectively prevent mCRPC recurrences and therefore PS can be
developed as effective recurrence preventer in mCRPC survivors. Aim 1: Efficacy of PS to
prevent mCRPC recurrence in nude mice and PCSK9 validation as a pathogenesis marker in
human PC tissues microarray. Assessments will compare PS potency in wild and PCSK9-
knockdown CWR-R1ca cells in adjuvant (post-primary tumor excision) mode and after
neoadjuvant enzultamide- docetaxel regimen followed by primary tumor surgical excision in nude
mice models. Biomax human tissue microarray will be used to validate PCSK9 relevance in
human PC. Aim 2: Assess the PS safety and pharmacokinetics in Swiss albino mouse models.
Expected outcomes: Proposed studies entail PS validation as a novel targeted intervention for
mCRPC recurrences prevention. PCSK9 targeting is a novel therapeutic alternative for long-term
prevention of metastatic castration-resistant prostate cancer recurrence in prostate cancer
survivors.

Public health relevance
NARRATIVE Metastatic castration-resistant prostate cancer (mCRPC) patients have poor progression and recurrence-free and overall survival rate with limited available treatment options. Current targeted and chemotherapies quickly develop resistance. Preliminary studies validated the microbial-derived natural product pseurotin A as a potential novel PCSK secretion and protein- protein interaction inhibitor appropriate for the control of mCRPC recurrence. The small molecular size of PS is advantageous over the FDA-approved humanized PCSK9 mAbs acting intra- and extracellular unlike the later which can act extracellular only. The proposed project will hit-to-lead promote pseurotin A for the prevention of mCRPC recurrence and metastasis in human-mimicking mouse models.